BLRD Research Career Scientist Award Application

Although CRC endangers males and females of all the population, the US (the United States of
America) Veterans show a higher incidence rate of colon cancer than the general population. It
is estimated that each year the Veterans affairs manages and treats ~175,000 CRC patients. It is
therefore an urgent necessity to find novel therapeutic strategies to curb CRC-malignancy to
increase the overall survival for the U.S. Veterans diagnosed with CRC as well as improve their
quality of life. Characterization of the key molecules involved in the processes critical for CRC
progression to develop novel and promising therapeutic approaches not only holds the promise
of decreasing the patient mortality amongst VA-CRC patients but also reduce the associated
financial burden for the Veterans Administration. The applicant’s lab program is focused on
understanding the molecular mechanism/s involving dysregulation of specific tight junction and
cell cycle proteins in Colon cancer progression and metastasis and developing targeted
therapeutics. Her laboratory is internationally known for its contributions in this area, especially in
understanding the role of Claudins in regulating CRC progression to metastasis and resistance
to conventional therapy. In this regard, extensive preclinical and clinical studies from her
laboratory, have validated a casual role for upregulated claudin-1 expression in promoting CRC
metastasis. Her laboratory is also the 1st lab which has developed a novel inhibitor for inhibiting
claudin-1 for inhibiting CRC. Her laboratory further demonstrated that claudin-7, yet another
claudin family protein, is a tumor suppressor in colon cancer. Her laboratory is also developing
patient-derived organoids, tumor xenografts from known disease stages and variable therapeutic
response, or have access to such reagents through her collaborations. The applicant has a broad
background in cancer biology, with published expertise in the regulation of colon carcinogenesis
and metastasis using in vivo and in vitro mouse, organoid and cell culture models. As a Research
Career Scientist, she will oversee this research program by coordinating the work done; designing
the experiments, delegating the work and monitoring the work to ensure that it progresses in a
timely fashion. She will also be involved in preparing manuscripts of the work performed and
presenting the results at conferences in this area of cancer biology, therapeutics in CRC patients.
Applicant’s research program has been continuously funded by VA Merit Award and multiple NIH-
grant awards for ~17 years. She has extensively published her laboratory work in over 75 original
peer reviewed research articles in prestigious journals in the field including Gastroenterology
(impact factor 33), GUT (Impact Factor 31) and J Clin Invest (19.4). In addition, one of the key
hallmarks of her program has been a multidisciplinary and collaborative nature of the research
enterprise with a deep focus on mentoring new generation of VA and affiliated university
investigators to enable them to establish their own independent research programs. She has been
successful at both the fronts: making new discoveries in the field and mentoring new generation
of young scientists and establishing a solid research environment at our local VA as well as at
affiliated university. This current application is intended to highlight the success of our program
and requesting RCS program to help us progress towards the new heights of success by nurturing
and mentoring a new generation of investigators.

Public health relevance
This proposal addresses a significant healthcare issue that affects Veterans, military personnel, and their families disproportionately to the general population. Here, work from Dr. Dhawan’s research program is focused on the investigation of mechanism/s and therapeutic targets in colon cancer progression and metastasis. Colon Cancer metastasis represent a major clinical challenge in the VA, since there are no current, effective therapeutic interventions, and metastatic colorectal cancer can result in therapy resistance and finally death. Work from her lab aims to provide a better understanding of mechanism/s of colon cancer progression and to increase opportunities for the development of novel treatment paradigms.